Effects of Alcohol and Tobacco Co-use on Momentary Subjective Cannabis Effects: Risks for Increasingly Hazardous Cannabis Use

PROJECT SUMMARY
The rates of cannabis co-use with alcohol and tobacco among young adults has continued to rise in recent
years. Considerable research has shown that co-use places individuals at greater risk for driving under the
influence, poorer mental-health and cognition, and co-morbid substance use disorders when compared to
single-substance use. Despite the increased prevalence and risk associated with the co-use of cannabis with
other substances, the mechanisms underlying these associations remains unclear. It has been hypothesized
that individuals engage in co-use to achieve greater subjective responses beyond that perceived with the use
of each substance alone. Given prior research has found inconsistent and null findings for outcomes related to
patterns of co-use, this suggests changes may be complex and require more careful examination of within-
person processes. Previous studies have also shown that subjective responses to cannabis may underlie or
coincide the development of cannabis use disorder (CUD); however, it is unclear from the existing literature
whether subjective drug effects of cannabis resulting from co-use with other substances, such as alcohol and
tobacco, increases the risk for hazardous use over time. The proposed study will utilize advanced statistical
methodology (e.g., multilevel modeling, longitudinal analyses) to examine ecological momentary assessment
and longitudinal data in young adult recreational cannabis users from a NIDA R01 project. Aim 1 of the
proposal will examine how cannabis co-use occasions with alcohol or tobacco (drug, ordering, timing) affects
subjective drug abuse liability effects of cannabis; and Aim 2 will examine whether these subjective responses
to co-use predict hazardous cannabis use one year later. Identifying underlying mechanisms of risk associated
with cannabis co-use will help to develop better tailored intervention approaches to decrease the public health
burden of CUDs among young adults.

Public health relevance
PROJECT NARRATIVE The co-use of cannabis with alcohol and tobacco is highly prevalent and is associated with greater risk for problematic outcomes than the use of each substance alone. However, the mechanisms underlying these associations remains unclear. The proposed project will utilize advanced statistical methodology to examine how cannabis co-use occasions with alcohol and/or tobacco affect momentary subjective drug abuse liability effects of cannabis and whether subjective responses to co-use lead to increasingly hazardous cannabis use over time in young adult recreational cannabis users. Findings from this mechanistic study may inform intervention approaches to decrease the public health burden of cannabis use disorders among young adults.